Use of post-acute care and outcomes among Medicare Advantage and fee-for-service beneficiaries

Project summary
Post-acute care (PAC) is common, and costly, and may not lead to optimal health outcomes for older adults.
However, it is unknown how to improve outcomes and/or lower costs, or value, of PAC. More than 40% of
Medicare fee-for-service (FFS) beneficiaries receive PAC after hospitalization, predominantly in skilled nursing
facilities (SNFs) and by home health (HH) agencies, at a cost of more than $60 billion annually. Unfortunately,
around 1 in 4 is readmitted to the hospital within 30 days of discharge to PAC, and nearly half of beneficiaries
in SNF fail to return to the community within 100 days of hospital discharge. The rapid expansion of Medicare
Advantage (MA) provides an opportunity to evaluate a different approach to PAC utilization. More than one-
third of all Medicare beneficiaries are now enrolled in Medicare Advantage (MA) plans, which receive capitated
payments and take financial risk for the care needs of beneficiaries. MA plan directors confirm in interviews
that PAC is a major focus of efforts to reduce care utilization and costs through four mechanisms: limiting use
of PAC overall; steering beneficiaries to less expensive forms (HH) instead of more expensive forms (SNF);
restricting choice of providers; and limiting PAC length of stay. Early reports suggest MA plans may strongly
influence PAC utilization. Whether reductions in PAC utilization in MA improve PAC value is unknown. The
limited existing literature has two main gaps: first, it does not adequately account for the substantial underlying
differences in the MA and FFS populations. Second, it has focused on short-term outcomes, while PAC likely
has a substantial impact on longer-term functional status and independence. Our overall goal is to inform
patients, providers, and policymakers about ways to improve the value of PAC for all Medicare beneficiaries.
To achieve this goal, we propose innovative analytic strategies that address limitations in the prior literature
and allow accurate assessment of the use and outcomes of PAC in similar MA and FFS beneficiaries. Our
aims are to: 1) Compare use of SNF and HH in similar MA and FFS beneficiaries after hospital discharge, and
the impact of different mechanisms for limiting PAC utilization; 2) Compare PAC outcomes (community days,
long-term institutionalization, rehospitalization, mortality) at 100 days and 1 year after hospital discharge in MA
and FFS; and 3) Evaluate the effects of MA versus FFS enrollment on specific subpopulations of patients
known to be at high risk for poor PAC outcomes. These results will provide novel insights into the effect of MA
plans on PAC use and outcomes, identifying potential benefits or unintended consequences that can shape
policy.

Public health relevance
Project narrative This project will examine the effects of Medicare Advantage (MA) plan influence on post-acute care use and outcomes. This is important because one-third of all Medicare beneficiaries are enrolled in MA plans, nearly half of all Medicare beneficiaries use post-acute care after hospitalization, and post-acute care is a major contributor to increased health care spending but frequently has adverse outcomes. Results will provide guidance on how to alter MA or Medicare fee-for-service practices in order to inform best practice in post-acute care.